4D virtual Catheter (4D vCath) for multi-factorial hemodynamics in pulmonary hypertension

SUMMARY: Pulmonary Hypertension (PH) is a severe and life-threatening disease that increases mortality rates
by 7-fold. Pulmonary Arterial Hypertension (PAH, WHO Group 1) is the most severe subtype, with a median
survival of just three years. PAH must be distinguished from another subtype called Pulmonary Venous
Hypertension (PVH, WHO Group 2) because PAH treatments can harm PVH patients. Unfortunately, the current
diagnostic and prognostic process for PAH is slow, taking 2-4 years after symptom onset, and relies on a series
of costly, inconclusive, noninvasive tests ending with invasive catheterization for conclusive diagnosis. Delays
and invasive diagnostics worsen patient suffering and jeopardize the chances of early effective treatment. Thus, there
is an urgent need for a streamlined, accurate non-invasive tool for PAH diagnosis, classification, and prognosis.
Our project aims to develop a '4D Right-Heart Virtual Catheter (vCath)' capable of providing a comprehensive
hemodynamic analysis of all right heart chambers in less than two minutes, utilizing a single 4D Flow MRI scan.
Our 4D vCath technology combines advanced mathematical modeling and fluid dynamics with 4D Flow MRI to
create a personalized digital catheter for streamlined, simultaneous analysis of multiple advanced hemodynamic
parameters. With our innovative solution, patients can receive a full set of diagnostic and prognostic
hemodynamic assessments of all right heart chambers from a single noninvasive MRI scan. Our technology
enables the accurate diagnosis of PAH, differentiation of PAH from PVH, and precise assessment of PAH
severity prognosis, eliminating the need for multiple costly tests, expediting early diagnosis, and enabling
personalized severity monitoring. This approach has the potential to widen access to essential care for
vulnerable PH patients who cannot undergo invasive CATH or multiple tests. Our multi-center project
encompasses 3 specific Aims: Aim 1: Develop an automated and rapid 4D RH vCath for a comprehensive
assessment of right heart hemodynamics and perform extensive inter-center and inter-vendor uncertainty
quantification in healthy controls. Aim 2: Conduct a multi-center cross-sectional study involving 165 subjects
from three sites (Northwestern, Mayo Clinic, and UT Southwestern), including PAH patients, PVH patients, and
healthy controls. The study aims to differentiate between PAH and PVH subtypes and assess the correlation of
4D vCath metrics with invasive Cath and MRI measures of right heart dysfunction in PH patients. Aim 3: Conduct
a multi-center longitudinal PAH outcome study, including a 1-year follow-up for PAH patients evaluating the
prognostic significance of 4D vCath for personalized evaluation and monitoring of PAH severity.
If successful, this project has the potential to revolutionize PH management by accelerating noninvasive
diagnosis, personalizing prognosis, and increasing access to timely care for a broader spectrum of patients
including those who are ineligible for invasive tests. This innovative approach holds promise for significantly
improving the outcomes and quality of life of individuals suffering from PH, particularly those with PAH.

Public health relevance
PROJECT NARRATIVE: We are tackling a deadly heart condition called pulmonary hypertension (PH), where the risk of death is seven times higher than normal. Our focus is on its most severe form, Pulmonary Arterial Hypertension (PAH), which usually gives patients only three years to live. Diagnosing PAH quickly and accurately is crucial because treatments are most effective only at earlier stages of the disease, and using its treatments on similar conditions can be harmful. However, current tests are expensive, complicated, invasive, and can take up to 4 years to provide the first diagnosis. By integrating mathematical modeling, advanced MRI imaging, and physics (fluid dynamics), this application goal is to develop a new, quick, noninvasive one-scan solution, the '4D Right-Heart virtual catheter’, to transform how we diagnose and monitor this life-threatening condition, offering faster diagnosis, better outcomes and making care more timely accessible to these suffering patients.